A 3D zebrafish microanatomical and gene expression atlas for disease modeling

Project Summary
The zebrafish is a vertebrate model organism with significant genetic, cellular, and physiological similarities with
humans. Its powerful genetic and imaging tools have allowed us to decipher gene function, embryonic
development, and disease mechanisms. Its small size and recent advances in imaging allow the unbiased
visualization of phenotypes across all cell types and tissues through adulthood. This creates a unique opportunity
for an integrative atlas resource that will allow the interpretation of multi-omic data in the context of the whole
organism. The labeled 3D whole-animal lifespan atlas will be based on microCT customized for histopathology,
histotomography that will, in turn, anchor 2D histological and developmental gene expression data to facilitate
understanding of normal and abnormal phenotypes.
Histology, the study of the microscopic structure of tissues, provides critical understanding of the organization
and function of tissue structure across organ systems. Clinical phenotypes are associated with altered gene
expression in specific cell types. Single-cell transcriptomic data are best interpreted in the context of the
microanatomy of the whole animal. Zebrafish is ideal for testing these principles based on the ability to image
the entire organism in 3D at cellular resolution.
The integrative zebrafish 3D microanatomical atlas will provide facile access to the first gene expression data
anchored on whole-organism, developmental stages, at subcellular resolution. Atlas integration will involve a
multi-disciplinary team of researchers with expertise in various fields, including histology, microscopy, imaging,
and genomics, and in interdisciplinary research. To ensure the accuracy and completeness of the atlas, we will
consult with experts in the field and incorporate feedback from the scientific community. The 2D histology
component of the atlases will include vector-based annotation of histology and histology like virtual slices from
3D high-resolution images of the organisms' cells, tissues, and organs. The 3D micro-CT component will consist
of cell-resolution 3D reconstructions of key structures, allowing researchers to interrogate spatial relationships
between different structures and to manipulate and explore the anatomy of the model organisms in virtual
environments. The gene expression component will involve generating both 2D spatial transcriptomic gene
expression data (2D spRNA-seq) and single-cell RNA-seq data for a zebrafish, integrating the two datasets to
assign cell types likely to be present in each 2D spRNA-seq spot, and performing in situ hybridization
experiments to validate the assignment of clusters in three dimensions.
A primary goal of this project is to maximize the impact of open-access multimodal, submicron resolution atlasing
by facilitating the dissemination of that knowledge across the scientific community. This atlas will comprise a
foundation for the long-term goal of applying this approach across model systems and humans that will, in turn,
accelerate a broad range of model organism research dedicated to the enhancement of human health.

Public health relevance
Project Narrative The proposed work will lay a firm foundation for an open-access, comprehensive, integrative 2D/3D reference atlas with gene expression data for zebrafish, enabling researchers to view transcriptomic data in tissue and organismal context in unprecedented detail. The 3D whole organism annotated atlas will include undistorted 3D histotomography reconstructions across developmental stages that will in turn anchor integrations with 2D histology that is the gold-standard for tissue phenotyping, including disease diagnostics and spatially-resolved gene expression analysis. This resource will then serve as a foundation for future translation to other model organisms and human atlases that can validate, anchor, and advance our understanding of biology, disease, and development for scientists and educators, ultimately contributing to breakthroughs in scientific discovery and improvements in human health, biomedical education and public health literacy.